The Impact of Yoga Supplementation On Cognitive Function Among Indian Outpatients

DESCRIPTION (provided by applicant): Schizophrenia (SZ) is a common, severe disorder for which treatment is inadequate and unpredictable at present. Its causation is uncertain. Its lifetime prevalence is approximately 1% world-wide. It is estimated that there are approximately 2.2 million SZ patients in the USA at present and over twice this number in India. As it is a lifetime condition, SZ entails enormous morbidity and public health costs, world-wide. Cognitive impairment is a key disabling feature of SZ. The impairment affects functional outcome and employability, resulting in increased burden. Currently, medications offer only modest benefits for the cognitive dysfunction. Hence, non- pharmacological interventions are worth consideration. Yoga is known to enhance cognitive abilities in healthy persons. Our preliminary studies have shown for the first time that there may be remarkable improvement in selected cognitive domains among outpatients with SZ. The improvement is unlikely to be due to rater bias, as they were noted using a computerized neurocognitive battery. Since our preliminary studies involved an open trial, it is necessary to conduct more controlled studies. To evaluate our results further, we propose to test the effectiveness of yoga supplementation using a controlled single blind design in India. Outpatients with SZ (N=258) undergoing treatment at a large academic center in New Delhi, India will be randomly assigned to one of the three groups- yoga training (YT, N=86), physical exercise (PE, N=86) or treatment as usual (TAU, N=86). The YT group will undergo 21 days yoga supplementation, while the PE group will complete a 21 day systematic physical exercise training regime. The third group will have no such supplementation. All patients will receive appropriate medications and counseling. Cognitive state, symptom severity and overall function will be assessed at four time points: just before, immediately after, three months later and six months after completion of YT/PE supplementation. The evaluations will be conducted by raters blind to group status. Thus, we will test a novel method to supplement the beneficial effects of pharmacotherapy more rigorously than in our pilot studies. Demonstrable benefits from YT will motivate further studies to test other important issues, such as dose effects of YT, its temporal benefits and its interaction with medications.

Public health relevance
PUBLIC HEALTH RELEVANCE: The proposed studies may lead to better treatment for schizophrenia using the ancient practice of Yoga. Our preliminary studies suggest significant beneficial effects of Yoga on cognitive function, which can be severely impaired in schizophrenia. The cognitive impairment is difficult to treat at present using medications. 7. Project Narrative The proposed studies may lead to better treatment for schizophrenia using the ancient practice of Yoga. Our preliminary studies suggest significant beneficial effects of Yoga on cognitive function, which can be severely impaired in schizophrenia. The cognitive impairment is difficult to treat at present using medications. __SpecificAimsTextDelimiter__ The impact of Yoga supplementation on cognitive function among Indian outpatients with schizophrenia. Cognitive impairment is a hallmark of schizophrenia (SZ). It affects the outcome of the disorder and markedly increases its burden. Various biological and psychological approaches are being tested to enhance cognitive capacity of these individuals, but the beneficial effects are modest. Yoga, the ancient Indian science of physical and mental fitness, offers a holistic approach to healthy life style and cognitive enhancement. Many studies have shown benefits of yoga for healthy individuals, and a few for psychiatric disorders. Despite its wide popularity, there are only a limited number of randomized, controlled yoga studies using objective quantitative outcome measures. Our preliminary studies have shown significant and substantial improvement in several domains of cognitive functioning among outpatients with SZ, using a simplified regimen in an open design. It is not clear if the benefits are due to physical activity alone or the entire yoga process per se. We propose to evaluate these results further, using a systematic random assignment design. Explanatory model The practice of yoga emphasizes body awareness and involves focusing one's attention on breathing or specific muscles or parts of body. We propose that the beneficial effects of yoga therapy (YT) observed in our preliminary studies relates to improvement in attention that extends to other cognitive domains. Hypotheses: 1. Yoga enhances attention, as well as related cognitive function among persons with schizophrenia. 2. Yoga has beneficial effects on the short term functional outcome of schizophrenia. Design A systematic, single blind randomly assigned supplementation of routine outpatient training with yoga, compared with standard physical exercise and treatment as usual. Specific Aims: We propose to evaluate consenting outpatients with SZ undergoing treatment at the Department of Psychiatry, PGIMER Dr Ram Manohar Lohia Hospital (RMLH), Delhi India (n= 258). Routine clinical management will be randomly supplemented with Yoga Training (YT, n = 86), directed Physical Exercise (PE, n = 86) or no supplementation (Treatment As Usual, TAU, n = 86). Treatment supplementation will last 21 days and all participants will be followed up for 6 months after completing supplementation. 1a. Recruitment: Outpatients at RMLH with a clinical diagnosis of SZ, who fulfill inclusion criteria will be approached and written informed consent obtained. 1b. Diagnosis: All participants will complete an exhaustive evaluation based on the Hindi version of the Diagnostic Interview for Genetic Studies (DIGS), supplemented with medical records. Consensus diagnoses will be established using DSM IV criteria. 1c. Randomization: The patients will be randomly assigned to one of the following three groups. Group assignment and ratings will be carried out by different individuals to enable single blind evaluations. Three types of supplementation are planned over 21 days. (i) Yoga Training (YT) (n = 86): Structured, simplified yoga instruction will be provided and supervised by a trained instructor in a group setting. (ii) Physical Exercise (PE) (n=86): Structured, physical exercises supervised by a trained instructor. (iii) Treatment as usual Group (TAU) (n=86): Participants who will continue in the department with clinical treatment as usual. No supplementation will be provided. Clinical treatment, including pharmacotherapy will be carried out as usual in all three groups. The treating physician will be blind to the type of supplementation. 1d. Assessment: Participants in all three groups will be assessed at study entry, at the end of the 21 day, and at three and six months after completing supplementation. The rater will be blind to the type of supplementation provided to the participant, if any. Cognitive assessment: The key assessment will be based on an efficient, validated computerized battery called the Computerized Neurocognitive Battery (CNB) (Gur et al. 2001a, 2001b). The assessment will be supplemented by the Information subscale of Post-graduate Institute Battery of Brain Dysfunction (PGI) (as an indirect assessment of intelligence) (Pershad and Verma 1990) and the Trail Making Test (Horton 1979), a pen and paper measure of working memory. Symptom assessment: The positive and negative symptoms will be assessed using the Scale for the Assessment of Negative Symptoms (SANS) and Scale for the Assessment of Positive Symptoms (SAPS) at baseline, three months and six months. After yoga/physical exercise SAPS and SANS will be done for the previous three weeks only. General Functioning: The Global Assessment of Function Scale (Endicott et al. 1976) will be used to measure the overall functioning of participants. Independent Living Skills Survey (Wallace et al. 2000): The basic functional living skills (Activities of Daily Living, ADL) of participants will be measured by Independent Living Skills Survey (ILSS) (Wallace et al. 2000) at every cognitive assessment point. 1e. Data analysis: Participants will be compared across three groups with regard to cognitive function and symptom severity, taking medications and other key covariates into account. The short term (21 day), medium term (3 months) and longer term (6 month) impact of supplementation will also be evaluated. This proposal outlines the first steps in a long term effort to evaluate novel therapies for disabilities due to SZ. We are aware of the potential pitfalls involved in such research. As budget limitations dictate our study design, we have planned evaluations with maximal rigor feasible under our operating circumstances. If the proposed studies indicate a beneficial effect of YT, further rigorous analyses will be planned; e.g., additional control groups, 'dose effects related to YT', control of concomitant medications, and interactions between YT and prescribed medications. Yoga has been promoted as a natural "cognitive enhancer" that could potentiate pharmacological interventions. In the form used by us, it is easy to teach. There are no invasive procedures. No side effects of yoga have been reported to date. India, and in particular our group at RMLH is uniquely poised to carry out this novel study.